Nanoparticles for In Vivo Labeling of T Cells During Cancer Immunotherapy

Project Summary
Despite decades of research, the prognosis for patients with malignant brain tumors remains poor and novel
treatment strategies are urgently needed. Malignant gliomas are particularly refractory to treatment, uniformly
fatal, and have not seen improvement in outcomes for over three decades. Immunotherapy has tremendous
promise for eradicating cancers with exquisite precision by leveraging the cytotoxic capabilities of tumor antigen-
reactive lymphocytes. Immune checkpoint blockade therapy blocking the programmed death 1 (PD-1) pathway
is used clinically against melanoma, non-small cell lung cancer, head and neck squamous cell carcinoma, renal
cell carcinoma, and Hodgkin's lymphoma. Although anti-PD-1 therapy alone is ineffective against malignant
gliomas, recent clinical trials with recurrent glioblastoma multiforme (GBM) suggest benefit of neoadjuvant anti-
PD-1 therapy prior to tumor resection. Preliminary results with an immunocompetent mouse model of recurrent
GBM suggests a role for CD8+ T cell recruitment during neoadjuvant anti-PD-1 therapy prior to tumor resection.
This Exploratory/Developmental Bioengineering Research Grant will develop technology to enable non-invasive
quantitative imaging of CD8+ tracer recruitment to the site of tumor resection using magnetic particle imaging
(MPI), a new imaging modality with potential advantages over immunoPET imaging. MPI tracers will be
formulated consisting of superparamagnetic iron oxide nanoparticles (SPION) with targeting motifs to selectively
label CD8+ T cells, enabling non-invasive, unambiguous, and quantitative imaging of their biodistribution.
Preliminary results show the PI has already developed MPI tracers with high sensitivity and long blood circulation
time. Selective in vivo labeling of T cells will be achieved by functionalizing these optimized MPI tracers with
antibody fragments that bind to T cell surface markers, resulting in internalization or persistent binding to the T
cell membrane. An important consideration in labeling T cells in vivo and in situ in solid tumors is penetration of
the imaging label. Preliminary results demonstrate accelerated and enhanced tumor accumulation of
systemically administered SPIONs through magnetic targeting. The PI hypothesizes that magnetic targeting of
T cell targeting SPIONs at the site of tumor resection will lead to increased SPION/T cell interactions and
increased sensitivity to the presence of T cells at the tumor resection site. In Aim 1 T cell labeling with the MPI
tracers will be optimized ex vivo and the effect of labeling on T cell viability and cytotoxic phenotype will be
evaluated. Then, in Aim 2 in vivo T cell labeling using systemically administered tracers will be evaluated in the
context of neoadjuvant anti-PD-1 therapy prior to tumor resection in a mouse model of recurrent GBM. The
proposed work will capitalize on magneto responsiveness of the SPION tracers to accelerate and enhance tumor
penetration using magnetic targeting. Success in the proposed research will add MPI as a tool in the growing
immunoimaging toolbox, helping accelerate development and mechanistic understanding of cancer
immunotherapies through in situ and in vivo labeling of CD8+ T cell biodistribution and recruitment to tumors.

Public health relevance
Project Narrative/Public Health Relevance Immunotherapy has immense potential to treat recurring cancer. Non-invasive quantitative imaging of immune cell accumulation in solid tumors is a powerful tool to evaluate response to therapy, providing scientists mecha- nistic insight and clinicians with information needed to make treatment planning decisions. This exploratory/de- velopment research project will develop nanoparticles for in vivo labeling and imaging of T cells during cancer immunotherapy using a new molecular imaging modality called magnetic particle imaging.